Validation of a novel EEG-based neurodiagnostic platform for assessing cognitive impairment and Alzheimer's Disease

PROJECT ABSTRACT
Alzheimer’s Disease (AD) is the most common cause of dementia, accounting for 80% of all dementia diagnoses.
In July 2023, the Alzheimer’s Association (AA) posted an update to their joint NIA-AA position on diagnosing AD.
It now requires biomarker evidence of AD-type pathology for diagnosis while also determining that biomarker
tests should not be ordered or interpreted in the absence of clinical context.
This new path for diagnosing and treating AD intensifies the need to ease the early, accurate, and accessible
identification of the patients who should undergo AD biomarker testing. Unfortunately, today’s techniques for
evaluating cognitive status and indicating the appropriateness of AD biomarker testing do not meet the clinical
need. These weaknesses hinder proper diagnosis of cognitive impairment, thereby limiting identification of
candidates for AD biomarker testing and treatment of AD.
To address these problems, SPARK Neuro is developing SPARK Scan, a standardized, objective, non-invasive,
and cost-effective diagnostic tool capable of identifying and staging cognitive impairment that is highly sensitive
to the presence of AD. In the proposed Phase II SBIR project, SPARK Neuro will build upon findings from a
successful Phase I in preparation for an FDA De Novo Submission and eventual commercialization. This effort
will include a pivotal clinical study (N=200) that will validate algorithm performance (Aim 1). Following this
validation, SPARK Neuro will finalize product software and cloud-based infrastructure, completing Verification
and Validation (“V&V) (Aim 2).

Public health relevance
PROJECT NARRATIVE Existing techniques for evaluating cognitive status and diagnosing Alzheimer’s disease (AD) do not meet the current clinical need. To address this problem, SPARK Neuro is developing the first-of-its-kind SPARK Scan technology, a standardized, objective, non-invasive, and cost-effective diagnostic tool. This cloud-based, neuroanalytic platform will constitute the first in-office, EEG-based diagnostic aid specifically developed for identifying AD and staging cognitive status, establishing the clinical context for diagnosing biomarker-defined AD and connecting patients to treatments for this devastating disease.